Contribution of Orexin System to Hypertension

SUMMARY
Hypertension is a major risk factor for cardiovascular disease, with salt sensitive hypertension (SSH)
accounting for 51% of all cases. As augmented sympathetic nerve activity (SNA) and dysregulated
neuroendocrine secretion are known to play critical roles in the development of SSH, w e propose a study
to investigate the mechanisms whereby hyperactivity of the brain orexin system, may critically influence SNA
and neuroendocrine dysregulation, thus contributing to SSH development.
Orexin A (OXA) is a multifunctional neuropeptide produced by hypothalamic neurons that plays various
physiological roles, including cardiovascular function, through binding with its receptors. Recent studies show
that upregulation of brain orexin signaling occurs in several animal models of hypertension suggesting
implications for overactive brain orexin signaling in hypertension development. However, the impact of orexin
system in the development of SSH and detailed molecular mechanisms underlying orexin system mediated
hypertension development are poorly understood. Our preliminary data shows that a high salt (HS) diet results
in hypertension, and significantly increases expression of OXA and orexin 1 receptor (OX1R) in the
hypothalamic paraventricular nucleus (PVN) of Dahl salt sensitive (Dahl S) rats, an animal model for human
SSH, but not in salt resistant rats. Interestingly, HS diet intake in Dahl S rats also increases OX1R expression
in adrenal glands, a component of hypothalamic-pituitary- adrenal (HPA) axis which is a central neuroendocrine
response system to combat stress and regulate multiple physiological functions. The PVN controls SNA outflow
and neuroendocrine hormone, such as vasopressin (AVP) and corticotropin-releasing hormone (CRH),
production. Central administration of OXA increases SNA outflow and PVN AVP expression as well as plasma
corticosterone levels, a hallmark of HPA axis activation. Hyperactivity of HPA axis is involved in multiple
diseases including hypertension. Lesions in the PVN prevent high salt induced hypertension in Dahl S rats.
This body of evidence suggests that PVN OX1R activation is involved in SNA and HPA axis regulation, and
increased PVN OXA-OX1R signaling induced by high salt intake may stimulate neuroendocrine systemic
secretion, trigger long-term adaptive changes through regulating downstream gene expression, producing
excessive excitatory neurochemicals, resulting in augmented PVN sympathetic tone, and leading to SSH. The
objectives of this project are: (i) investigate whether chronic knockdown of PVN OX1R expression decreases
plasma corticosterone levels, attenuate HS induced increase in SNA, and prevent SSH; (ii) elucidate the
molecular mechanism underlying the relationship between OXA-OX1R and its augmentation of SNA and
dysregulation of HPA axis. A combination of in vivo gene transduction, electrophysiological recordings, and
molecular and biochemical approaches will be employed to answer our questions using salt sensitive and
normotensive rat models. Our studies may identify new targets for therapeutic intervention in hypertension.

Public health relevance
NARRATIVE Salt sensitive hypertension (SSH) is responsible for 51% of all cases of hypertension in the United States, and is a major risk factor for development of cardiovascular disease with serious social and economic impacts. Our preliminary data suggests that abnormal orexin signaling in the paraventricular nucleus (PVN), a major cardiovascular control brain region, may increase sympathetic outflow and upregulate hypothalamic-pituitary- adrenal (HPA) axis following a high salt intake, resulting in the development of SSH. Our study proposes to investigate the role and mechanism of orexin signaling in the development of SSH by means of genetic knockdown or chronic overexpression of the PVN orexin receptor combined with electrophysiological recording, as well as molecular and immunohistochemical approaches to further elucidate the signaling pathways that lead to excitatory neurochemical release, inflammation, and subsequent increased SNA outflow and dysregulated HPA axis.